FINANCIAL MANAGEMENT SERVICES IN SUPPORT OF DCR SPECIAL PROJECTS (GUINEA SERVICE CENTER) FOR CONTRACT #HHSN2201700050I.

This funding supports core clinical research infrastructure to facilitate multicenter, randomized, controlled clinical trials on Ebola virus, HIV, Malaria, and other infectious diseases in Guinea.